Fentanyl Addiction: Individual Differences, Neural Circuitry, and Treatment with a GLP-1 Receptor Agonist

Project Summary
Opioid use disorder (OUD) is defined in the DSM-V as a “problematic pattern of opioid use leading to problems
or distress”. More than 36,000 people overdosed on synthetic opioids including fentanyl in 2019 and, with the
COVID-19 pandemic, there has been a 30% increase in overdose deaths.1,2 Current treatments for OUD
include therapy and medication-assisted treatments (MATs) such as methadone, buprenorphine, and
naltrexone. Naltrexone has low compliance rates and there is stigma associated with the use of methadone
and buprenorphine, as they are opioids used to treat OUD. Access to these drugs, then, is limited, and relapse
rates remain high.3-6,46 Relapse often is precipitated by withdrawal and withdrawal, we hypothesize, is a need
state.7 Thus, as the need for fluid is sated by water, for example, the need for drug (i.e., withdrawal) is sated by
drug. In accordance, we further hypothesized that glucagon-like peptide-1 (GLP-1), a satiety drug, could be
utilized to reduce drug seeking and taking in rodent models of OUD. In support, GLP-1 targeted treatments are
effective in reducing responding for many substances of abuse in rodent models.8,55-56,72 Additionally, we found
that GLP-1 receptor agonists (GLP-1RAs) can reduce heroin self-administration, cue-induced heroin seeking,
and drug-induced reinstatement of heroin seeking.9,24 GLP-1RAs also reduce oxycodone taking and seeking.15
Finally, our preliminary data suggest that a GLP-1RA can reduce cue- and drug-induced seeking of not only
heroin, but fentanyl as well (Urbanik et al., in preparation). This finding is consistent with a recent report.13 With
fentanyl contributing to the majority of opioid overdoses1, it is critical that we understand where in the brain
fentanyl is acting and how treatment with a GLP-1RA might mitigate these effects. Here we will use rodent
models, light sheet microscopy, qRT-PCR, and pharmacology to address these questions. For our rodent
model, we will utilize an extended access drug self-administration paradigm.22 We predict that: (1) As with
other drugs of abuse tested,16,22-23 half of the rats tested will be high drug takers and these rats will have higher
cue-induced seeking and greater inhibition of the GLP-1 ‘satiety’ pathway and greater activation of reward
substrates compared to low fentanyl taker/seekers. (2) Fentanyl intake, fentanyl seeking, brain activation
patterns, and gene expression will be attenuated by treatment with the GLP-1RA, liraglutide. (3) The protective
effects of GLP-1RA treatment on behavior and brain will be blocked by the administration of the GLP-1R
antagonist, exendin-9 (Ex-9), directly into the lateral hypothalamus. These hypotheses will be tested across
three specific aims. If our hypotheses are supported, we will have identified the most vulnerable of fentanyl
taking and seeking rats, rescued these subjects from fentanyl seeking via treatment with a GLP-1RA, verified
that fentanyl, particularly in the most vulnerable, inhibits the GLP-1 ‘satiety’ pathway and activates
reward/seeking substrates, and implicated a key role for GLP-1 receptors in the lateral hypothalamus – a
structure critically involved in homeostasis and motivated behavior.

Public health relevance
Project Narrative Opioid use disorder (OUD) ruins the lives of those with the disorder and those around them, while also placing higher healthcare and economic burden on the United States. Here we will use drug self-administration and light sheet microscopy to identify the impact of high vs. low fentanyl seeking on brain in male and female rats and we will test the ‘need-state’ hypothesis by determining whether treatment with a glucagon-like peptide-1 receptor agonist (GLP-1RA) not only rescues vulnerable rats from fentanyl seeking but also reengages the GLP-1 ‘satiety’ pathway and disengages substrates involved in reward and seeking.